POSSIBLE VISIT TO LFD &AVAILABLE EQUIPMENT

1. Spoke of possible visit to LFD and the available equipment here. 2. Discussed the protein systems being examined and preliminary experiments which could be done at Mass General Hospital